Food-based Randomized trial for Enhancing Support of Hospitalized children and their families (FRESH)

PROJECT SUMMARY
Nationally, 1 in 7 families with children are food insecure. Childhood hunger is associated with worse health
and developmental outcomes; children in low-income families also experience more urgent healthcare
utilization. During pediatric hospitalization, low-income parents/ caregivers (hereafter referred to as parents)
experience hunger due to an inability to afford enough food in the hospital. This hunger may increase parent’s
mental “fog” and reduce their ability to be present during the hospitalization. The hospitalization itself causes
financial strain due to missed work and increased medical and non-medical expenses during the
hospitalization; this strain is especially true for low-income families. Pediatric hospitalization is an opportunity to
intervene and support families that go hungry in the hospital and lessen the burden going home after
hospitalization. At our institution, we instituted an in-hospital food support intervention on one inpatient unit
to provide meal cards for our cafeteria for all parents of children insured by Medicaid or uninsured, which
reduced parental hunger rates from 86% to 16%. Hospital leadership has asked our study team to spread it
throughout the hospital. Additionally, we partnered with parents to design a post-discharge food support
intervention that provides grocery gift cards and frozen meals to families who identified household food
insecurity. We tested this intervention in the clinical system with high ratings of feasibility, acceptability, and
appropriateness from a diverse group of family participants. We will compare these interventions to usual
care, as-needed social work referral. In our first aim, we will determine the effect of the in-hospital food
support intervention on parent-reported and clinical outcomes, such as hunger, parent presence in the
hospital, post-discharge urgent healthcare use, and time to return to normal routines after hospitalization. We
will evaluate this intervention using a stepped-wedge randomized trial, where the unit of randomization is the
clinical unit. Our second aim will determine the effect of the post-discharge food support intervention on
parent-reported and clinical outcomes, including sooner return to work and school and urgent health care
reutilization. This aim will be evaluated through a nested randomized control trial within the stepped wedge
design. Our parent-centered and experienced study team is well-poised to complete the proposed project. Our
three parent co-investigators bring diverse backgrounds and experiences to our study team, and our co-
investigator team has worked together on many successful projects. Our Stakeholder Advisory Board is
composed of both local and national stakeholders who are committed to this project and the dissemination of
our findings.

Public health relevance
PROJECT NARRATIVE Childhood hunger and household food insecurity are significant public health problems that impact child and family health and wellbeing. Pediatric hospitalization is a key timepoint for which to screen and intervene to reduce parental hunger during hospitalization and household hunger in the challenging post-discharge transition period. The results of this study will determine if either or both an in-hospital or post-discharge food support intervention improve short-term outcomes for patients and their families.